NON-GLP, ORAL TOXICITY AND TOXICOKINETIC STUDIES OF DRUG MOLECULES IN RODENTS AND NON-RODENTS

NON-GLP, ORAL TOXICITY AND TOXICOKINETIC STUDIES OF DRUG MOLECULES IN RODENTS AND NON-RODENTS

Public health relevance
Development of treatment for neurological disorders